Mosquito larval immunity and its impact on gut microbiota and malaria competence

DESCRIPTION (provided by applicant): Malaria vector competence is largely determined by ecological interactions among mosquito gut microbiota, Plasmodium, and host immunity in the context of gut microenvironment. Mosquito immunity studies have been mainly focusing on the adults. Larva-pathogen interaction is an unignorable driving force in shaping mosquito immune system during the evolution. However, little is known about larva immune structure and its interaction with gut microbial flora. In this project we propose to use larvicidal Bacillus sphaericus to study mosquito larval immune response, and characterize larval immune architecture by using microarray based global expression profiling. The impact of larval immune activation on the dynamics of gut microbiota in both larvae and adults will be assessed by profiling gut bacterial community via high throughput pyrosequencing bacterial 16S rDNA marker. The influence of these parameters on the malaria susceptibility will also be evaluated. The project will generate data towards a better understanding of larval immunity and its impact on mosquito gut ecosystem.

Public health relevance
Mosquito larva-bacterium interactions contribute to the evolution of immune system. This proposed project initiates a study on larval immune responses upon exposure to larvicidal bacterium Bacillus sphaericus and its impact on mosquito gut microbiota and malaria susceptibility. This pilot project will generate data towards comprehensive understanding the tripartite ecological interactions among malaria, gut microbiota and host immunity and its impact on vectorial capacity.